Core--Biobehavioral measurement

The primary objective of the Biobehavioral Measurement Core (BMC) is to provide timely and cost-effective solutions to the measurement problems encountered by MRDDRC investigators. This objective is met through the achievement of five specific objectives. These specific objectives are: 1. To consult with investigators about problems and solutions relevant to measurement 2. To design effective solutions to measurement problems 3. To develop the necessary software and/or hardware to effect a solution. 4. To maintain the hardware and software instruments used by Center investigators in their research. 5. To training and educate investigators about new developments in relevant measurement approaches and technologies.